Immunity to Cryptosporidium

Cryptosporidium causes self-limiting diarrheal disease in immune competent individuals and life-threatening illness in
young children as well as patients with defects in T cell function. Current drugs are poorly efficacious, and a vaccine would
be a game changer for the pediatric disease. However, there is a major gap in our understanding of what types of protective
immunity would be required for successful vaccination. Based on clinical and experimental studies, we know CD4+ T cells
and the production of IFN-γ are important for parasite control but the actual events that restrict Cryptosporidium are
unknown. The advent of parasite molecular genetics has transformed the ability to modify Cryptosporidium and in the last
funding period these laboratories have generated the tools needed to answer fundamental questions about the mechanisms
of resistance to this organism. Remarkably, while IFN-γ is important for parasite control, in vaccination experiments we
also found significant protective CD4+ T cell dependent memory even in the absence of IFN-γ and our studies implicate IL-
22 in resistance to Cryptosporidium. Based on this foundation, the vision of this proposal is to leverage our advances in
parasite biology, mouse models, and immunological tools to understand: 1) the relationship between the IFN-γ and IL-22-
mediated pathways 2) Utilize the differential activities of STAT1 and STAT3 in enterocytes to understand the basic
mechanisms that promote parasite clearance 3) Use of novel genetically attenuated parasite strains to understand the parasite
and host factors required for long term CD4+ and CD8+-T cell mediated protective immunity. The studies propose here will
deliver information on the innate and adaptive pathways that promote T cell mediated control of Cryptosporidium and how
EC responses limit parasite growth. This information is relevant to understanding the type of long-lived cellular immunity
required for vaccine protection from Cryptosporidium, and insight into how to best target this response to the gut to reduce
both parasite burden and damage to the tissues. We expect the mechanisms discovered in the course of this program to be
of broad interest to the understanding of numerous diseases of the intestinal tract of infectious, inflammatory and malignant
etiology.

Public health relevance
Project Narrative Cryptosporidium is one of the most important causes of diarrheal disease in the U.S. and around the world and a vaccine is urgently needed to protect young children. This project will identify the host and parasite factors that lead to the development of long-lived cell mediated mechanisms that underlie protective immunity.